EFFECT OF ARTIFICIAL, NONDIGESTIBLE NONABSORBABLE FAT ON HUMAN GI TRANSIT

To determine whether the motor function of the GI tract of healthy volunteers is altered by an absorbed form of fat that is a nonapproved food additive.